Functions of Epstein-Barr Virus LMP2A in Latency

DESCRIPTION (provided by applicant): Over 90% of the population harbor EBV-latently infected cells. After a typically benign primary infection of B cells, EBV transitions to a latent state in which the virus expresses few viral transcripts to avoid immune recognition. These latently-infected cells are believed to be the precursors for EBV-associated lymphomas, including Burkitt's lymphoma, Hodgkin's and Non-Hodgkin's lymphoma. An EBV protein that is expressed during latency and by EBV-associated tumors is Latent Membrane Protein 2A (LMP2A). LMP2A enhances B cell survival and accelerates tumor onset. Preliminary data for this proposal indicate that LMP2A enhances mitogen-induced B cell proliferation and the production of IL-10, which is a cytokine that promotes B cell proliferation and survival. Therefore, LMP2A-mediated increases in IL-10 production may impact the maintenance of viral latency and the generation of EBV-associated lymphomas. The hypothesis for this proposal is that LMP2A enhances B cell proliferation by increasing B cell IL-10 production. Experiments using both LMP2A-expressing and LMP2A-negative cell lines, in addition to B cells derived from murine LMP2A transgenic mouse models will test this hypothesis. In Aim 1 we will use quantitative Realtime RT-PCR, ELISpot, and intracellular IL-10 staining to confirm that LMP2A increases mitogen-induced IL-10 production. In Aim 2 we will use cell lines containing wildtype LMP2A and mutant forms of LMP2A to determine the residues of the cytoplasmic tail of LMP2A required to increase IL-10 production. Additionally, we will use pharmacologic inhibitors that inactivate targets of LMP2A to determine the proteins required to increase IL-10 production. Finally, in Aim 3 we will inactivate the IL-10 signaling pathway using a neutralizing anti-IL-10 antibody and inhibitors specific for the IL-10 receptor signal transduction pathway to determine if LMP2A-dependent increases in IL-10 mediate the hyperproliferation of LMP2A-expressing B cells. Understanding the mechanisms by which LMP2A increases B cell proliferation and IL-10 production will advance our knowledge of how LMP2A maintains EBV latency and promotes EBV-associated cancers. PUBLIC HEALTH RELEVANCE: Over 90% of the population harbor B cells latently infected with Epstein-Barr Virus (EBV) that is associated with the development of lymphomas, such as Burkitt's lymphoma, Hodgkin's lymphoma and Non-Hodgkin's lymphoma. This proposal will expand our understanding of how EBV increases the production of the cytokine IL-10 to increase proliferation and survival of B cells. Findings from these studies will not only help us to understand the biology of EBV, but also to identify mechanisms by which EBV promotes tumor development.

Public health relevance
PROJECT NARRATIVE: Over 90% of the population harbor B cells latently infected with Epstein-Barr Virus (EBV) that is associated with the development of lymphomas, such as Burkitt's lymphoma, Hodgkin's lymphoma and Non-Hodgkin's lymphoma. This proposal will expand our understanding of how EBV increases the production of the cytokine IL-10 to increase proliferation and survival of B cells. Findings from these studies will not only help us to understand the biology of EBV, but also to identify mechanisms by which EBV promotes tumor development.